In vivo SELEX strategies to identify potent aptamer-drug conjugates for glioblastoma

PROJECT DESCRIPTION/ABSTRACT
Development of effective therapies for glioblastoma (GBM) remains a major challenge despite decades of
intensive research. Coupled with intra-tumoral heterogeneity and plasticity, the infiltration of normal brain tissue
by GBM cells poses unique therapeutic challenges. Further, the specialized neurovascular unit that forms the
blood-brain barrier (BBB) is partially intact in GBM and results in heterogeneous, sub-therapeutic delivery of
most cytotoxic chemotherapies to regions of every GBM. We have previously shown that the efficacy of
otherwise highly potent antibody-drug conjugates is specifically limited in GBM by poor delivery across the
BBB. Like antibodies, single-strand DNA aptamers fold into unique 3-dimensional shapes with epitope binding
affinities that rival those of antibodies, and some aptamers also efficiently traverse the BBB. In contrast to the
laborious development of antibody-based therapeutics, the integration of solid-support synthesis, PCR
amplification, and next-generation sequencing technologies enable massively parallel screening strategies,
known as ‘systematic evolution of ligands by exponential enrichment (SELEX)’, to identify individual DNA
aptamers with desired physical and biological features through successive rounds of negative and/or positive
selection. Based on prior experience with this strategy, we hypothesize that tumor-specific DNA aptamer-drug
conjugates (ApDCs) optimized for distribution across the BBB can be efficiently identified using in vivo SELEX
with libraries of aptamer-drug conjugates and orthotopic GBM patient-derived xenografts. To address tumor
heterogeneity, in vivo selection will be performed across multiple PDXs, and single cell sequencing technology
will be leveraged to identify ApDCs that bind to diverse subsets of tumor cells and not normal cells within the
brain. The goal of this application is to develop a robust platform for efficient screening of GBM-specific
ApDCs. This will be accomplished by addressing three Aims.
Aim 1 – R61: Optimize design and sequencing of aptamer-toxin libraries
We will optimize strategies for toxin conjugation during library processing through multiple SELEX rounds.
Extending our preliminary data demonstrating MMAE toxin stability to PCR thermal cycling, we will optimize
toxin-conjugated PCR primers for library preparation and single-cell RNA/aptamer-seq.
Aim 2 – R61: Determine optimum training round strategy to identify brain tumor-specific ApDCs
We will optimize the time between DNA library injection and tissue collection. We also will evaluate a novel
SELEX reward strategy based on selectively capturing aptamers only after cleavage of MMAE from an ApDC.
Aim 3 – R33: Apply in vivo SELEX with orthotopic GBM PDXs to train ApDC libraries
In vivo SELEX will be performed with an ApDC library across a heterogenous set of orthotopic GBM PDXs to
understand the potential for targeting heterogeneous tumor and sparing normal cell populations.

Public health relevance
PUBLIC HEALTH RELEVANCE Glioblastoma (GBM) is the most common primary brain tumor in adults, is essentially incurable, and is associated with significant morbidity. In this project, we will develop a novel class of targeted cytotoxic therapies using DNA aptamers (single-stranded folded DNA molecules) conjugated to potent cellular toxins. The goals of this project are to identify individual aptamer-drug conjugates for treatment of GBM and to provide a roadmap for how these aptamer-drug conjugates could be easily identified for essentially any cancer.